Understanding the genomic basis of problematic alcohol use through integrative analysis of multi-omics data

This project seeks to further the understanding of the genomic etiology of alcohol use disorder (AUD). Genetic
studies have identified loci associated with the disorder; however, the genetic architecture of AUD has not been
fully explained. Currently, genome-wide variant data of the disorder are available for analysis, and functional
genomic datasets are being generated from consortia. Sequencing data from biobanks would allow assessment
of the contribution of coding and functional non-coding regions to AUD risk by using a proxy phenotype from the
information of the Alcohol Use Disorder Identification Test (AUDIT) report. Prior work has shown that 1) AUD
has a high genetic overlap with some neuropsychiatric disorders (NPDs), and 2) common-variant studies identify
biological pathways associated with the disorder. Therefore, integrative analyses which incorporate multi-omics
datasets and overlapping genetic information can help identify additional loci associated with the disorder. Thus,
the candidate plans to use integrative methods to 1) increase power for genetic discovery, and 2) better
understand the genomic architecture for AUD. AUD has a high genetic correlation with the AUDIT-based
phenotype (AUDIT-P) which assesses the problematic consequences of drinking. AUD and AUDIT-P have
similar genetic correlations with other NPDs. Multiple AUDIT-P datasets are publicly available, and a recent
meta-analysis of AUD and AUDIT-P datasets shows increased statistical power for risk loci identification. For
this reason, this proposal centers on identifying the genomic association for problematic alcohol use which
includes AUD itself and/or AUDIT-P. To achieve this research goal, the candidate proposes the following aims.
First, he plans to extend his previous methods to jointly analyze rare exonic variants and other omics datasets.
Second, he will develop methods to integrate common variants, omics information and genetic overlap
information to increase power for multi-trait analysis. Third, he proposes an integrative method to analyze rare
variants from whole-genome sequencing data. Fourth, he will apply these methods to analyze large-scale variant
and functional-genomic datasets. He plans to use systems biology approaches to elucidate analysis results from
these methods. Also, he proposes using genetic model organisms (C. elegans) to better understand the results
from computational approaches via RNA interference and CRISPR-Cas9 experiments. Dr. Nguyen has a
background in mathematics, statistics and statistical genetics; however, he has not had prior experience in the
field of genetics of AUD. The mentor team including leading experts in the field will help him to 1) gain expertise
in the basic principles of psychopathology, alcohol related phenotypes, the nosology of NPDs and alcohol related
phenotypes; 2) acquire understanding of genetic model organisms, RNAi and CRISPR-Cas9 experiments for
validation of computational results; 3) gain expertise in additional types of omics data; and 4) develop needed
independence in his career. These training goals will aid him in successfully conducting the proposed work, and
building a NIH-funded translational research program focused on AUD and its comorbid conditions.

Public health relevance
Alcohol use disorder (AUD) affects millions of people in the US. Although genetic studies have identified loci associated with AUD, its genetic etiology has not been fully explained. This project aims to 1) develop integrative methods for analyzing large-scale genomic datasets of AUD to increase power for genetic discovery, and 2) elucidate the genomic architecture of AUD by using systems biology approaches.